Mechanisms of Signaling Protein Retention in the Primary Cilium

PROJECT SUMMARY
The primary cilium is a solitary membrane extrusion from the apical surface of noncycling resting
cells in mammals. It functions as a sensory organelle that is responsible for the resting cells to sense
environmental conditions and communicate with adjacent cells. This organelle is composed of a
microtubule-based axoneme encased in the plasma membrane, resulting in formation of a ciliary
compartment that is separated from the cytoplasm by a transition zone at its base. Protein trafficking
within the ciliary compartment is mediated by intraflagellar transport that transverses the compartment bi-
directionally on the microtubules. Accumulating evidence suggests that the ability of the primary cilium to
function as a sensory organelle depends on selective accumulation of various signaling molecules. Many
components of cilium-dependent pathways are found to be transported into and out of the primary cilium
in response to environmental cues. However, the mechanisms underlying the regulated trafficking remain
unknown.
The proposed application is to define a previously unknown mechanism in intraflagellar protein
trafficking that as suggested by our preliminary data, regulates ciliary accumulation of soluble protein
kinases in response to flow stress and chemical stimulation. This novel mechanism is mediated by
folliculin (FLCN), a tumor suppressor, of which defects cause the Birt-Hogg-Dube (BHD) syndrome, a
genetic disorder that is manifested clinically by benign tumors and cystic growth in multiple organs. In
ciliated resting cells inactivation of FLCN produces profound effects on several major cilium-dependent
pathways, including the Sonic Hedgehog (Shh) pathway, which becomes fully active and unresponsive to
ligand stimulation. Preliminary data suggest that FLCN couples Shh ligand stimulation to ciliary
accumulation and activation of Smoothened (Smo), a key but poorly understood step in Shh signaling.
The application is proposed to define the underlying molecular basis and its functional significance in
general ciliary signaling. Three lines of investigation will be carried out in the context of ligand and flow
stress regulated Shh signaling. including: 1) determining how FLCN-mediated ciliary protein accumulation
controls Smo activation in response to Shh ligand stimulation; 2) determining the role of Rab23 small
GTPase in the ciliary function of FLCN; 3) determining how flow stress controls Shh signaling through
FLCN. Successful completion of the proposed studies will offer a new paradigm to explain how ciliary
signaling is regulated by environmental cues and elucidate the mechanism underlying the Shh ligand-
induced activation of Smo.

Public health relevance
PROJECT NARRATIVE When mammalian cells exit cell cycle and enter quiescence, a majority of them forms a unique microtubule-based organelle termed the primary cilium that projects from the cell surface. This once regarded as a vestigial structure has recently been found to play a pivotal role in regulating cell differentiation, cell cycle entry, cell polarity during development and maintenance of tissue homeostasis. Defects in this organelle are associated with a large numbers of pleiotropic disease conditions in human, collectively called ciliopathy, including polycystic kidney disease, nephronophthisis, and Bardel-Biedl syndrome. The primary cilium functions as a cellular antenna for cells to sense environmental conditions and to coordinate signaling activities that dictate cell function. Its signaling activity depends on selective accumulation of various signaling molecules within the ciliary compartment that is separated from the cytoplasm. Protein trafficking into and out of the compartment is carried out by intraflagellar transport and regulated by extracellular physical and chemical signals. However, the mechanism underlying the regulated protein trafficking within the primary cilium remains largely unknown. The proposed application is to define the molecular basis for the regulated trafficking and to understand how the trafficking events of signaling molecules are integrated with their biochemical activities. Successful completion of the proposed study will provide insights into a fundamental mechanism in cell signaling and help us to understand why defects in this unique cell organelle cause a wide spectrum of pathophysiological conditions in human.